Toll-like receptors: full-length human TLR3 and the signaling protein hUNC93B1

Full-length human TLR3 was subcloned into a pENTR/TOPO vector with C-terminal FLAG- and His-tags. From this Gateway entry vector two expression vectors were generated: one for baculovirus expression and the second one for stable mammalian expression. The baculovirus expression system and HEK293 cells with stable expression will be used, that provide correct glycosylation and folding of the target proteins. Full-length TLR3 is a membrane protein, and is expected to be present in the insoluble fraction of a cell lysate. Preliminary results in insect cells show low levels of expression in the soluble fraction and higher levels in the insoluble fraction. Our goal is to determine the high resolution crystal structure of the full-length TLR3 complexed with double-stranded RNA. Since TLR3 has a single membrane-spanning alpha-helix, the signaling complex with 2 membrane-spanning helices may be a more stable candidate for crystallization experiments and structure solution. For structural studies, full-length TLR3 might be further stabilized by complexing it with hUNC93B1. Human UNC93B1 is a membrane protein essential in signaling by TLR3, TLR7/8 and TLR9. It is a relatively poorly characterized protein localized in the ER. A missense mutation in the mouse Unc93b1 gene abrogates signaling via the nucleotide-sensing TLRs. Cells from UNC93B1-deficient patients have compromised signaling via TLR3, 7, 8 and 9. It was shown that UNC93B1 binds to TLRs via their transmembrane domains. It was also shown that the UNC93B1-TLR complex may reach lysosomes without passing through the Golgi, and the interaction between UNC93B1 and TLRs also controls TLR trafficking. Co-expression of the hTLR3 with hUNC93B1 will also be explored.